Harmonized Diagnostic Assessment of Dementia (DAD) for Longitudinal Aging Surveys in India (LASI)

Project Summary/Abstract:
In this application, we are seeking supplemental funding for Wave 2 activities of the Longitudinal
Aging Study in India (LASI). This application builds upon LASI and its allied study, LASI-DAD, a
nationally representative survey focused on late-life cognition and dementia in India. The main
LASI survey provides socioeconomic and other behavioral data for LASI-DAD respondents,
which are not collected as part of the LASI-DAD survey. This information is essential to achieve
the aims of the parent LASI-DAD grant, specifically related to assessing cognitive changes over
time, understanding their correlates, and estimating the economic and caregiving burdens of
dementia. This application seeks funding for the efforts by the HSPH and USC teams to help
International Institute for Population Sciences with for the implementation of the follow-up
interviews of Wave 1 LASI respondents (N~74,000) as well as newly age-eligible respondents
within the sampled households in 36 states and union territories of India. Specifically, this
application aims to conduct the following: 1) updating and programming the Wave 2 instrument,
including the addition of a new COVID-19 module and capturing socioeconomic changes during
the unplanned 4-year delay of LASI Wave 2; 2) conducting pretests and refining the research
instrument; 3) tracking the sample; 4) training trainers and field investigators; 5) implementing
real-time data monitoring and quality control measures; and 6) obtaining ethical clearance for
future genomics studies. Dr. David Bloom and Dr. Jinkook Lee will lead the investigative team
for LASI Wave 2 at HSPH and USC respectively. These activities are critical for ensuring quality
assurance and harmonization of the LASI survey with the Health and Retirement Study and its
international network of surveys.

Public health relevance
Project narrative: This funding application seeks support for the implementation of Wave 2 of the Longitudinal Aging Study in India (LASI). Wave 2 of LASI plays a pivotal role in advancing our understanding of the aging process in India, addressing the unique challenges faced by older adults, and facilitating the formulation of policies and programs to enhance their well-being and quality of life. Furthermore, the data collected during LASI Wave 2 will provide crucial backing for the Longitudinal Aging Study in India- Diagnostic Assessment of Dementia (LASI-DAD). LASI-DAD's data will significantly contribute to our understanding of dementia prevalence, incidence, cognitive changes over time, and the comprehensive evaluation of the economic and caregiving burdens associated with dementia, both at the population level and among diverse demographic groups.